UNM COBRE: CORES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Integral to the COBRE CETI program are two core facilities, the Molecular Biology Core (MBF) and the Controlled Environment Facility. Both facilities offer state-of-the-art equipment for COBRE CETI researchers as well as students, faculty and visiting researchers wishing to conduct experiments using modern molecular methods and/or requiring precise environmental control. The facilities are staffed by one full-time Research Scientist who is partially COBRE supported and two Research Assistants who are supplied by the Department of Biology. These staff are available to help users in running facility equipment as well as assist with data analysis.